Optimization of a carbon monoxide (CO) sensing hemoprotein for applications as an antidote for CO poisoning and a biosensor for CO detection in living cells

PROJECT SUMMARY/ABSTRACT
Carbon monoxide (CO) inhalation is a leading cause of human poisoning in the United States, resulting in about
50,000 cases and at least 1,500 deaths annually, as well as long-term cardiac and neurocognitive sequelae for
one-third of survivors. Unfortunately, no point of care antidotal therapy exists for CO poisoning to date. A field-
deployable agent that irreversibly scavenges and sequesters CO could serve as an improved therapeutic that
increases survival and long-term outcomes for patients suffering from CO poisoning. In this proposal, we will
exploit the uniquely strong and specific interaction between CO and ferrous heme by utilizing a hemoprotein
scaffold to develop a high-affinity CO scavenger. We recently discovered a remarkable hemoprotein domain,
found in the bacterial CO-sensing transcription factor RcoM (regulator of CO metabolism), that exhibits a 900-
fold increase in CO binding affinity compared to hemoglobin, the primary biological target in acute CO poisoning.
This RcoM hemoprotein also shows exquisite selectivity for CO over oxygen, a critical property for a CO antidote
that will be infused intravenously in humans under oxygenated conditions. In Aim 1, we will utilize in vitro
spectroscopic methods to identify 1) the minimum functional RcoM subunit, and 2) key amino acid residues that
confer high CO affinity, selectivity, and heme stability. In Aim 2, we will evaluate the safety and efficacy of the
three RcoM truncates with highest CO affinity and selectivity in vivo. We will assess systemic and organ-specific
effects of intravenous RcoM delivery in healthy mice and quantify the ability of infused RcoM to scavenge CO,
reverse hemodynamic collapse, and prevent death in a severe preclinical mouse model of CO poisoning. The
outcomes of these aims will provide fundamental insight into hemoprotein ligand selectivity and demonstrate the
therapeutic potential of recombinant RcoM as a treatment for acute CO poisoning. While toxic at high
concentrations, CO, endogenously produced as a by-product of heme degradation, serves as a cytoprotective
signal at low concentrations. Preclinical and clinical studies have explored the use of CO as a therapeutic under
conditions ranging from infection to ischemia/reperfusion injury. Despite potential clinical benefits, the roles of
CO as a signaling molecule are poorly understood, and the CO concentration regimes corresponding to basal
signaling, cytoprotection, and toxicity are poorly defined. A genetically encoded, CO-selective fluorescent
reporter would be the ideal tool to tease apart physiological roles of CO in living systems. In Aim 3, we will
employ the CO-sensing function of RcoM to design a genetically encoded fluorescent reporter, characterize CO-
dependent response in vitro, and incorporate this reporter into the mouse genome using CRISPR/Cas9. We will
quantify CO accumulation in transgenic reporter mice under different CO exposure conditions and define regimes
that give rise to CO signaling, cytoprotection, and toxicity in vivo. Through this aim, we will develop critical
biomolecular tools that will enable elucidation of CO-dependent signaling mechanisms relevant to human health.

Public health relevance
PROJECT NARRATIVE When inhaled at high concentrations, carbon monoxide causes cardiac and neurocognitive deficits and death; however, when produced at low concentrations in tissue, carbon monoxide acts as an intracellular signal and has even been tested as a therapeutic agent. In this proposal, we aim to develop a microbial carbon monoxide sensor, RcoM, into (1) a fast-acting carbon monoxide scavenger that can serve as an antidote for carbon monoxide poisoning and (2) a sensitive detector of carbon monoxide in living cells. Development of these molecular therapeutics and tools will dramatically improve the current standard of care for carbon monoxide poisoning and advance our understanding of intracellular carbon monoxide signaling and toxicology, with the potential to substantially decrease death and disability caused by this common poisoning.